The Optical Probes Conference: Discovery to Application

Abstract
The discovery of novel optical probes underpins myriad biological imaging approaches
and assay technologies. This conference will explore the latest advances in the
development of probes for elucidating biological processes. We aim to bring together
researchers in the fields of chemistry, spectroscopy, molecular sensing, biological
imaging and advanced imaging technologies in order to foster new national and
international collaborative projects. We also want to encourage and support junior
investigators/trainees, women and minority scientists to launch innovative molecular
probes and enhance our ability as a community to collectively tackle challenging
biomedical questions.
This conference will bring together scientists engaged in a wide range of probe
development and application efforts. Speakers and attendees will include a broad
community of synthetic/ physical organic chemists, protein design experts, and
biology/biophysics-oriented scientists.

Public health relevance
Narrative This grant will help to fund a new conference dealing the discovery of optical probes for biological imaging. This conference will bring together scientists engaged in a wide range of probe development and application efforts. Speakers and attendees will include a broad community of synthetic/ physical organic chemists, protein design experts, and biology/biophysics application-oriented scientists.